ASTERISK: Alcohol and Substance use Treatment and Engagement Research on Intervention Studies among Key populations

PROJECT SUMMARY
Alcohol and substance use disorders (ASUD) are associated with substantial morbidity and mortality. Globally
alcohol use disorders (AUD) were attributed to 99.2 million disability-adjusted life years (DALYs) while illicit
substance use disorders (SUD) were attributed to 31.8 million DALYs lost in 2016. Despite the urgent need to
reduce the public health impacts of ASUD and scale up efficacious interventions, treatment uptake worldwide
remains low. Psychosocial and structural factors are major barriers to ASUD treatment and engagement. For
example, psychological distress, polysubstance use, homelessness, incarceration, and engagement in sex work
have been associated with lower ASUD treatment coverage and completion. When these factors co-occur, they
may also generate synergistic negative effects that contribute to less optimal health outcomes and greater
disease burden (defined as syndemics). Less research has empirically examined the syndemic effects of
psychosocial and structural barriers on ASUD treatment and treatment engagement. To optimize ASUD
treatments and maximize engagement, there’s an urgent need to examine the syndemic relationship of these
conditions, especially across multiple and diverse studies. To address these gaps, Dr. Santos proposes to
expand his patient oriented research (POR) program, and expand his capacity to train early stage investigators
(ESIs), particularly those from underrepresented backgrounds. Dr. Santos will provide experiential training for
ESIs in three complementary POR projects (Projects A, B, and C) that will examine the barriers to ASUD
treatment access and engagement, and explore treatment preferences of individuals with ASUD. Project A will
examine the syndemic effects of psychosocial and structural conditions on the use of ASUD treatment (AIM 1),
and the moderators of those effects (AIM 2), leveraging five National HIV Behavioral Survey cycles (cumulative
n=3848) using an Integrative Data Analysis (IDA) approach. Project B will examine the syndemic effects of
psychosocial and structural conditions on ASUD treatment outcomes (AIM 3), and the moderators of those
effects (AIM 4), leveraging 10 ASUD pharmacotherapy trials (cumulative n=722), also using an IDA approach.
Project C will examine the preferred treatment attributes of individuals with ASUD using Discrete Choice
Experiments (DCE; AIM 5) and examine how preferences differ between groups (AIM 6) among 250 individuals
with ASUD. Ultimately, the findings from this study will be fill critical gaps in ASUD treatment implementation,
particularly for key populations disproportionately impacted by HIV. In parallel to these research projects, Dr.
Santos will provide structured mentoring and training to ESIs in three key areas of support: instrumental,
professional and social. Instrumental support will focus on building ESIs capacity to become independent
researchers. Professional support will focus on career development skills to thrive in research. Finally, social
support aims to increase their social capital and resilience through networking opportunities, group social
activities, and individual coaching.

Public health relevance
PROJECT NARRATIVE Alcohol and substance use disorders (ASUD) is a major public health issue and studies to examine barrier to ASUD treatment access and engagement, as well as preferences for treatment are needed. This project will leverage individual-level data across multiple studies to examine barriers to ASUD treatment access and treatment engagement. It will also examine on the ASUD treatment preferences to enhance services for individuals with ASUD.